Mechanism of Par1c-mediated AMPA receptor trafficking and synaptic plasticity

Project Summary/Abstract
The human brain is remarkably unique in its high capacity to learn and adapt to new environments, which has
been attributed to the plasticity of synaptic connections. One form of synaptic plasticity, long-term potentiation
(LTP), is associated with AMPA receptor trafficking to the surface of dynamic postsynaptic protrusions called
dendritic spines. GluA2-deficient mice show enhanced LTP, supporting that regulation of synaptic surface
GluA2 levels is important for LTP expression. However, the mechanism underlying GluA2 trafficking and how
this translates to changes in synaptic plasticity is unclear. We have unexpectedly identified a significant
increase in synaptic GluA2 in the hippocampi of forebrain-specific conditional knockout (cKO) of partitioning
defective 1c (Par1c), also known as microtubule affinity-regulating kinase 1 (MARK1) mice. In addition, these
mice exhibit reduced spine formation and impaired spatial learning. This suggests a potential role for Par1c in
synaptic plasticity and cognitive functions through regulation of GluA2 trafficking. Importantly, genetic evidence
supports that Par1c functions in higher level cognition. Single nucleotide polymorphisms (SNPs) in MARK1
have been associated with autism spectrum disorder (ASD) and bipolar disorder. Furthermore, MARK1 is
highly expressed in forebrain pyramidal neurons and exhibits human-specific accelerated evolution, suggesting
its importance in the development of cognition. However, the role of Par1c in AMPA receptor trafficking and
synaptic plasticity remains unknown. Considering Par1c cKO mice show a significant increase in synaptic
GluA2, we hypothesize that Par1c promotes synaptic plasticity by limiting GluA2 trafficking to the
spine surface. When Par1c is knocked out, there will be increased synaptic incorporation of GluA2-containing
AMPA receptors, leading to reduced spine density and impaired learning. Interestingly, unbiased
phosphoproteomic analysis of Par1c cKO hippocampi revealed 7 of 17 significantly dysregulated proteins are
associated with endocytic trafficking. Thus, Aim 1 will test the hypothesis that Par1c regulates GluA2 trafficking
through phosphorylation of a potential novel target of Par1c identified through phosphoproteomic screen. Aim 2
will determine if synaptic plasticity induction requires Par1c activation using a novel, synaptic-targeted
photoactivatable Par1c. The proposed work will elucidate the role of Par1c in regulating AMPA receptor
trafficking and synaptic plasticity. Importantly, this project will train the applicant in multidisciplinary techniques
including molecular biology, biochemical assays, FRET and FRAP imaging, primary neuronal cultures, and
electrophysiology. It will also provide opportunities for the development of critical thinking, written and oral
communication skills, and the execution of rigorous and reproducible science. The thorough mentorship and
resources available to the applicant combined with her extensive and interdisciplinary neuroscience
background will ensure her development into a successful, independent scientific professional.

Public health relevance
Project Narrative The human brain is remarkably unique in its high capacity to learn and adapt to new environments, which has been attributed to the plasticity of synaptic connections. MARK1, which encodes partitioning defective 1c (Par1c), is a gene that has human-specific accelerated evolution and is associated with autism spectrum disorder (ASD) and bipolar disorder, suggesting a role for this protein in learning and memory. This project aims to describe a molecular mechanism of Par1c-mediated synaptic plasticity and learning through AMPA receptor trafficking.